Analgesic Mechanism of Action of Endogenous Opioid Peptides Enkephalins with a Fo

PROJECT SUMMARY The endogenous opioid system regulates pain sensitivity and is targeted by opioid drugs used in the clinic (e.g. morphine) for the management of pathological (disease- or injury-induced) pain. However, current opioid therapies generate significant side effects (i.e. paradoxical hyperalgesia, drug abuse, vomiting, constipation, respiratory depression, etc) and have limited efficacy for the treatment of certain types of chronic pain (i.e neuropathic pain). The endogenous opioid system is composed of several peptide agonists (including enkephalins) and of the delta, kappa and mu opioid receptors (DOR, KOR and MOR, respectively). The contribution of individual opioid receptors and peptides to pain processing has been probed by pharmacological and gene knockout approaches, but surprisingly little is known about the mechanisms by which interactions between these peptides and receptors regulate pain. The objective of the proposed research is to better understand how enkephalins and opioid drugs regulate pain transmission in the spinal cord, where neuroplastic changes leading to chronic pain occur, to develop new therapeutic strategies to treat morphine-resistant types of chronic pain. We will first investigate the cellular mechanisms by which enkephalins regulate activity of spinal neurons known to be critical to chronic pain. We will test the hypothesis that because of distinctions between DOR and MOR cellular biology (e.g. expression by different neurons, different trafficking properties or subcellular localization) activation of the two opioid receptors differentially alters neuronal activity. We will then investigate spinal enkephalinergic circuits and identify both the neurons responding to enkephalins and the opioid receptors mediating these responses (DOR and/or MOR). We will test the hypothesis that release of enkephalins inhibits neighboring projection neurons known to be critical to chronic pain, as well as enkephalinergic neurons themselves (autosignaling). Finally, we will use behavioral assays to test the hypothesis that enkephalinergic neurons are critical to setting pain threshold during chronic pain. The proposed studies should greatly improve our understanding of the mechanisms by which the endogenous opioid system controls pain. In addition, these studies might provide an explanation for the limited efficiency of current therapies and stand to uncover new opioid-based strategies to manage chronic pain. Additionally, both the innovative methods developed in this project and the new information obtained is expected to have a broad impact on our understanding of the mechanism of action of opioid drugs, beyond the pain field (i.e. drug addiction). The mentor, Dr. Amy MacDermott, has a distinguished reputation for productive and relevant research on electrophysiological studies of the spinal pain circuitry. In addition, she has a strong track record of supervising trainees who go on to become productive, independent researchers. Columbia University provides a high-quality environment for the development of Dr. Scherrer's career and research plans. The research facilities, educational opportunities, and intellectual environment are outstanding and will contribute greatly to the success of the proposed activities.

Public health relevance
PUBLIC HEALTH RELEVANCE Opioid drugs such as morphine are widely used for the treatment of severe pain despite generating significant side effects (vomiting, constipation, respiratory depression, drug abuse, etc) and having limited efficacy for the management of certain types of chronic pain (neuropathic pain). The goal of the proposed studies is to understand the mechanisms by which opioid drugs relieve pain and generate side effects to develop more efficient and safer drugs to treat pain. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The endogenous opioid system regulates pain sensitivity and is targeted by opioid drugs used in the clinic (e.g. morphine) for the management of pathological (disease- or injury-induced) pain. However, current opioid therapies generate significant side effects (i.e. paradoxical hyperalgesia, drug abuse, etc) and have limited efficacy for the treatment of certain types of chronic pain (i.e neuropathic pain). To develop analgesics efficient against morphine-resistant chronic pain, we need to better understand how the endogenous opioid system modulates pain transmission in the spinal cord, where neuroplastic changes leading to chronic pain occur. The endogenous opioid system is composed of several peptide agonists (including preproenkephalin gene- derived enkephalins) and of the delta, kappa and mu opioid receptors (DOR, KOR and MOR, respectively). These opioid receptors are G-protein coupled receptors that modulate common cellular effectors to inhibit neurotransmission. Enkephalins have a high affinity for DOR and MOR and can recruit both receptors to produce pain relief. In the spinal cord, enkephalins are released by interneurons located in the dorsal horn, and DOR and MOR are expressed by neighboring projection neurons as well as by enkephalinergic interneurons (autosignaling). What distinguishes DOR- and MOR-mediated enkephalinergic signaling and whether these two modes of enkephalinergic neurotransmission differentially contribute to chronic pain control is unknown. My hypothesis is that the distinct contributions of the two receptors underlie the fine-tuning of pain threshold by enkephalins. I propose to use an innovative combination of electrophysiological, genetic and behavioral approaches to determine how enkephalins can reduce chronic pain by acting at DOR and MOR. I will first investigate the cellular mechanisms by which enkephalins regulate activity of spinal neurons known to be critical to chronic pain. In Specific Aim 1, I will test the hypothesis that because of distinctions between DOR and MOR cellular biology (e.g. expression by different neurons, different trafficking properties or subcellular localization) activation of the two opioid receptors differentially alters neuronal activity. I will then investigate spinal enkephalinergic circuits and identify both the neurons responding to enkephalins and the opioid receptors mediating these responses (DOR and/or MOR): I will test the hypothesis that release of enkephalins inhibits neighboring projection neurons known to be critical to chronic pain, as well as enkephalinergic neurons themselves (autosignaling) (Specific Aim 2.a.). Finally, I will use behavioral assays to test the hypothesis that enkephalinergic neurons and enkephalinergic autosignaling (via DOR or MOR) are critical to setting pain threshold during chronic pain. (Specific Aim 2.b-c.). Together, these studies will uncover the analgesic mechanism of action of enkephalins at the level of the spinal cord and should contribute to the development of new opioid-based strategies to treat chronic pain. Specific Aim 1 (K99). To test the hypothesis that activation of DOR or MOR differentially alters the electrophysiological properties of spinal neurons known to be critical to chronic pain. 1.a. To determine the effect of DOR or MOR activation on neuronal activity and test whether DOR- and MOR- mediated responses can be recorded in the same neurons. 1.b. To determine whether DOR and MOR can differently alter neuronal activity because of their distinct trafficking properties. 1.c. To determine whether DOR and MOR regulate neuronal activity in distinct subcellular compartments (e.g. dendrites vs. soma). Specific Aim 2 (R00). To identify neurons responding to enkephalins in the spinal cord and test the hypothesis that spinal enkephalinergic neurons are major contributors to the control of chronic pain. 2.a. To use channelrhodopsin-2 stimulation of enkephalinergic neurons and electrophysiological recording of neighboring neurons to identify spinal neurons that respond to enkephalins. 2.b. To use behavioral assays and specific ablation of enkephalinergic neurons to determine the contribution of spinal enkephalinergic neurons to acute and chronic pain. 2.c. To use behavioral assays and specific deletion of opioid receptors (DOR and/or MOR) in enkephalinergic neurons to determine the contribution of enkephalinergic autosignaling to acute and chronic pain.